Adding Rhesus Macaque to the Alliance

Summary
We propose to incorporate the rhesus macaque (Macaca mulatta) genome into the Alliance of
Genome Resources (Alliance). This one-year project would serve two main purposes. First, it will
bring a non-human primate into the Alliance, which will deeply connect knowledge about this
important research organism to other research organisms and provide useful features for the
macaque research community. Second, it will provide preliminary results and a path forward for
a robust knowledgebase project for other non-human primates to be associated with the Alliance.
It will also serve as a proof of principle for the Alliance’s agility and scalability. In collaboration
with an existing and already interested resource, mGAP (the Macaque Genotype and Phenotype
Resource), we will systematically bring information about this macaque genome and genetics into
the Alliance. Starting with existing macaque resources (e.g., mGAP for variants, phenotypes, and
disease connections) as well as generic resources (NCBI for genome; GOC for Gene annotations;
BioGrid/IMEX for molecular interactions; Reactome; OMIM). The Oregon National Primate
Research Center (ONPRC) has been interested in joining the Alliance for five years, and we are
now ready to engage fully. In particular, the Alliance is well on its way to having an extensible
persistent store with a rich-data model handling variants, disease annotations; gene expression;
GO annotations; interactions and so forth. We will populate these with macaque data over the
year. As the macaque data are incorporated, we will provide for macaque the full suite of features
available on the current Alliance site, and others as they become available. Specifically, we will
provide a macaque landing page with community-specific content; a community forum; gene
pages for all macaque genes; orthology calls for protein-coding genes; an interactive table of
variants; disease annotations; a JBrowse2 instance that will visualize variants as well as gene
structure models; automated descriptions of gene function that will head each gene page; table
of Gene Ontology (GO) annotations; pathways from Reactome and GO-CAM; gene expression;
and molecular interactions. Together this will provide a useful resource to the growing non-human
primate genome biology community and its connection with a broader set of biomedical
researchers.

Public health relevance
Macaque in the Alliance Paul Sternberg, Paul Thomas, Don Conrad Narrative The Alliance of Genome Resources is using shared genome knowledgebase infrastructure development to harmonize data about major biological models to deploy and maintain resources in an efficient manner, and to allow better comparative genomics and genome biology. We propose to integrate genomic and related data for the rhesus macaque into the Alliance of Genome Resource infrastructure. This will provide a large user community with an enhanced resource for the macaque, and, critically, relate this information to human genetics and genomics along with the other model organisms already in the Alliance.